Role of FSH in postmenopausal obesity and breast cancer

ABSTRACT
There is strong and consistent evidence for an association between obesity and post-menopausal breast
cancer; however, the exact mechanisms are not clear. Follicle stimulating hormone (FSH) increases with
menopause, concomitant with increased adiposity, particularly visceral adipose tissue (VAT). Recent
preclinical data suggests that FSH may drive the deleterious shift in adiposity, independent of estrogen (E2).
Further, FSH receptors are now known to be expressed in breast tumors. To date, there have been no large-
scale human investigations of these FSH-adiposity-breast cancer associations. Using the Women's Health
Initiative (WHI), a long-term national epidemiologic study of postmenopausal women, we will test the
hypothesis that FSH drives adiposity postmenopausally, both cross-sectionally and longitudinally. Large
subsets of WHI participants completed repeat dual energy x-ray absorptiometry (DXA) scans, and therefore
have available robust measures of adiposity (including a novel measure of VAT) and banked serum from the
randomized hormone therapy trials (N=1400) and the observational study (OS; N=1499). Second, using a
case-control design, we will test the hypothesis that higher baseline FSH levels associate with increased risk of
breast cancer using adjudicated cancer incidence data spanning >25 years follow-up (N=785 cases; N=2510
non-cases). Further, we will determine whether adiposity mediates the FSH-breast cancer risk associations.
For all analyses, we will account for exogenous HT use (conjugated equine estrogen ± medroxyprogesterone
acetate or reported HT use in the OS), endogenous estrogen (E2), and adipose-derived hormones that directly
or indirectly regulate FSH (e.g. leptin). Our study is the first comprehensive epidemiologic investigation of FSH
and obesity to measure and study FSH levels in the years prior to breast cancer diagnosis to assess the
potential role of FSH in breast cancer. This study, which includes rich hormone and body composition data will
enable immediate translation to more precise breast cancer prevention interventions aligned with new
medications in the pipeline or currently in use for other cancers and osteoporosis, such as FSH and FSH
receptor modulators, upstream GnRH antagonists (e.g. goserelin), and estetrol (E4).

Public health relevance
PROJECT NARRATIVE This study is focused on the topic of postmenopausal shifts in follicle stimulating hormone (FSH) and how FSH relates to obesity development and breast cancer risk. The results will provide insight into obesity-breast cancer mechanisms and will enhance our ability to target preventive therapies. Based on study results, hormone-related medications on the market or in development can be tested specifically for breast cancer prevention.